Scientific Computing

The Office of Scientific Computing Services (OSCS) provides scientific and technical expertise in advanced biomedical computing and clinical informatics in support of the NIH Intramural Research Program; supports, maintains, and provides access to advanced supercomputing platforms for use by the NIH biomedical research community; works with NIH Institutes and Centers to support the use of mathematical and computer science approaches to advance biological and biomedical research efforts in medical informatics, data visualization, natural language processing, data mining, biological and medical database integration, and related areas; and develops novel computational methodologies and centralized database solutions to address and advance emerging biomedical research initiatives and challenges. OSCS is comprised of three functional groups: (1) The Cloud Computing Services group manages NIHs cloud computing infrastructure and provides associated technical and scientific support for NIH research programs; supports NIH-wide data science strategic planning initiatives and implements plans for modernizing the NIH-funded biomedical data science ecosystem; operates the NIH Science and Technology Research Infrastructure for Discovery, Experimentation, and Sustainability (STRIDES) Initiative, through which NIH and NIH-funded researchers can access cloud-based technologies and related services from STRIDES partners to apply to their research; and provides training and other services to researchers, data owners, and research support staff across NIH to ensure optimal use of available tools and technologies. (2) The Scientific Application Services group develops advanced algorithms and data visualization applications that are comprehensive and extensible; implements known solutions, algorithms, or methods to quickly and efficiently meet the biomedical imaging and informatics needs of NIH intramural collaborators; applies or develops novel systems, applications, algorithms, models, and machine learning techniques to efficiently deliver trusted data analysis; and collaborates with NIH intramural researchers to support biomedical informatics and data science services across research, clinical, and operational entities to shorten the path from data to insight. (3) The High Performance Computing Services group plans, manages, supports, and operates NIH's core enterprise-wide, high-performance computational environment in support of NIH intramural research; develops and supports biomedical and life science application programs, associated biomedical databases, programming languages, and tools; provides training and technical expertise for NIH intramural staff relating to NIH high-performance computational resources and scientific applications; and researches new technology developments in high-performance computing, life science applications, biomedical databases, and high-performance storage and network archiving for use by NIH.